Evolution and resolution of ARDS molecular phenotypes

ABSTRACT. The acute respiratory distress syndrome (ARDS) is associated with high mortality, morbidity, and
health care costs (Bellani 2016). Dozens of candidate drugs for ARDS have been identified in preclinical
models, but none consistently reduced mortality in randomized controlled trials (RCTs). This dismal record is
likely driven in part by the heterogenous biology encompassed within the definition of ARDS (Rubenfeld 2015).
Unsupervised clustering of plasma biomarkers and clinical variables recently identified two molecular
phenotypes of ARDS (Calfee 2014) which may enable predictive enrichment in future RCTs. Uncertainty about
the key biologic mechanisms that distinguish these two phenotypes from each other remains a critical
knowledge gap. The overall objective of this proposal is to recruit patients to an established cohort of
mechanically ventilated patients and identify distinct mechanisms of lung injury in ARDS molecular
phenotypes. The central hypothesis of this proposal is that ARDS phenotypes are driven by different
dysregulated pathways that result in distinct clinical trajectories and responses to treatment. In Aim 1, I will use
single cell RNA sequencing to study tracheal aspirates and develop a model of cell signaling in the lung of
each molecular phenotype. I hypothesize hyperinflammatory ARDS is associated with increased Type 1 T-cell
polarization and a diminished response to interferons in macrophages. In Aim 2, I will use metatranscriptomic
sequencing to characterize differences in the tracheal aspirate microbiome in each phenotype. I hypothesize
TA metatranscriptomes will have distinct microbial community composition in each phenotype, which will be
characterized by increased burden of enteric bacteria in the hypoinflammatory phenotype and an increased
burden of fungi in the hyperinflammatory phenotype. In Aim 3, I will collect longitudinal tracheal aspirate and
plasma samples to study the evolution of pro-inflammatory, pro-resolution, and pro-fibrotic pathways in each
ARDS phenotype. I hypothesize ARDS phenotypes have distinct trajectories of inflammation and repair
pathways in the first week of mechanical ventilation. I will address a critical gap in knowledge required to
develop phenotype-specific precision treatments. This K23 award is sponsored by Dr. Carolyn Calfee, an
experienced ARDS researcher whose group has pioneered analyses of ARDS molecular phenotypes, and Dr.
Stephanie Christenson, a computational biologist with expertise in the transcriptomics of airway diseases.
Their mentorship and the research and training plan in this K23 will support my continued career development
and allow me to learn essential skills I require to be an independent investigator, including advanced
computational analyses, epidemiological methods, and management of a research cohort. Developing these
skills will be essential to achieve my long-term goal of understanding the mechanistic pathways distinguishing
ARDS phenotypes to identify novel potential therapies. The proposed aims lay the foundation for a R01
proposal to study the interaction of pulmonary and systemic inflammation in ARDS phenotypes.

Public health relevance
Narrative Recently described molecular phenotypes of the acute respiratory distress syndrome (ARDS) have distinct clinical trajectories and differential responses to treatments in secondary analyses of randomized controlled trials, but the mechanisms underlying these differences are poorly understood. The research proposed in this K23 will use tracheal aspirate RNA sequencing to identify the cellular circuits driving dysregulated pulmonary inflammation, test for the differences in microbial communities, and study the evolution and resolution of ARDS in each molecular phenotype. These aims complement a training plan designed to prepare me to apply for an R01 grant to study the interaction of pulmonary and systemic inflammation in ARDS phenotypes as an independent investigator within 5 years.